Identification of optimum spectacle prescriptions for patients with Down syndrome

Project Summary/Abstract: It is known that individuals with Down syndrome (DS) have reduced visual acuity
which may result from high levels of refractive error (sphere and cylinder) and elevated levels of higher-order
aberrations that are present from childhood. Targeting optical aberrations through spectacle correction with
refractions determined objectively from measures of wavefront aberrations is part of our long-term goal to
provide new treatment strategies to improve vision in this group. The central hypothesis is that measures of
visual and retinal image quality (metrics) can be used to identify sphere and cylinder corrections that optimize
vision, resulting in multi-line acuity gains over traditional corrections. Our previous evaluation of these
corrections in adults with DS found improvement in acuity, but not the multi-line levels predicted. We propose
that this mismatch in acuity gains is attributed to decades of exposure to poorly corrected optical deficits that
has resulted in a reduction in visual acuity potential (i.e. refractive amblyopia). Further, the method is inherently
monocular, and does not prescribe refractions reflective of the two-eyed visual experience of the patient, as
would occur in a clinical exam. The short-term goal of this work is to address these proposed barriers to multi-
line acuity improvements with metric-optimized refractions through a randomized treatment trial conducted in
children with DS who are within the optimal age for treatment of amblyopia. This trial will compare acuity
outcomes for three refractive methods: 1) metric-optimized refractions, 2) clinical refractions, and 3) a hybrid
method that allows for clinical refinement of the metric-optimized refraction. In addition, we seek to improve the
objective refraction process by removing dilation prior to the wavefront imaging necessary to compute the
metric values, as well as determining the rate of change in refraction during extended follow-up to guide patient
recall times (i.e. follow-up intervals) for updated refraction. This work will be accomplished through three
specific aims: Aim 1) Compare refractions and resultant visual acuity obtained from wavefront measures pre-
and post-dilation. Aim 2) Compare visual acuity outcomes of metric-optimized, clinical, and clinically-refined
metric-optimized refractions in a treatment trial of children with DS. Aim 3) Determine rate of change in
refraction as a function of age and refractive error type annually over four years in children and adults with DS.
Metric-optimized refraction is innovative in that it compensates for the absence of subjective input in the
refraction process for the DS population and allows the clinician to consider corrections targeting overall image
quality. This proposed research is significant in that it proposes to use spectacles in an optimized manner to
remove visual barriers. Treatment of refractive amblyopia with multi-line acuity gains would lead to lifelong
benefits, including access to traditional print size, facilitate educational efforts, and facilitate activities of daily
living, all of which may promote greater independence. This work is similarly applicable to other patient
populations who cannot fully participate in subjective refractions (young children, cognitively impaired, etc.).

Public health relevance
Public Health Relevance: Over 400,000 individuals in the United States have Down syndrome (DS) and are living with the significant challenges of cognitive and visual deficits, both of which pose serious threats to the maximum potential of these individuals. Improving visual health remains the primary mission of the National Eye Institute, and becomes particularly critical when the affected individuals cannot advocate for themselves, such as is the case for persons with DS. This proposal aims to test new objective spectacle prescribing strategies to provide improvements in visual quality for individuals with DS which is ultimately anticipated to improve their performance of visually demanding activities of daily living and foster greater independence.